Predoctoral Training Program in Molecular Pharmacology

We are submitting this application in the program area of Pharmacological Sciences (PS). The primary
goal of the PhD Training Program in Molecular Pharmacology and Experimental Therapeutics (MPET) in
the Mayo Clinic Graduate School of Biomedical Sciences (MCGSBS) is the development of independent
investigators capable of directing outstanding research programs in academia, industry, or other settings.
The faculty is comprised of 28 well-funded, independent investigators who are drawn from departments
and divisions across the institution and who focus on a continuum of research areas encompassing
studies from basic molecular and genetic aspects of disease through drug discovery and development of
novel therapies for diseases. The faculty provides training opportunities in areas that include systems
pharmacology, artificial intelligence, computational chemistry, molecular mechanisms of drug action and resistance, metabolomics, novel therapeutic strategies, the genetics of addiction, preclinical and clinical pharmacology, and pharmacogenomics of genes associated with drug responses. Forty-six predoctoral students (PhD and MD/PhD in PhD training), from varied scientific backgrounds in pharmacology, are currently enrolled in the MPET PhD training program. A rigorous didactic curriculum includes a series of Core Curriculum courses that ensure strong fundamental knowledge in biochemistry, molecular biology, genetics, statistics, cell biology and pharmacology, as well as a series of tutorial-based courses that provide advanced training in pharmacological sciences. During their first two years of study, students complete laboratory rotations and select a laboratory for their thesis research. They complete comprehensive written and oral qualifying examinations by the end of Year 3. Training in rigor and reproducibility is woven throughout the training program, and students are expected to meet the highest standards of scientific integrity. After developing a written thesis proposal delineating the questions and approaches to be pursued in the thesis research, the Thesis Advisory Committee reviews the proposed research at the first committee meeting. Students present work-in-progress updates on their research projects to MPET faculty and students each year. Trainees are required to develop independence and to publish at least one first-author article. In the last 15 years, MPET trainees have averaged over 2.2 first author articles and 5.6 total articles. Starting in Year 3 and beyond, students meet with their Thesis Advisory Committees at least twice per year. The average time to completion of the PhD is 5.9 years. Graduates of the MPET PhD training program have outstanding track records, with many students establishing new research directions that have long-lasting impacts on the mentor’s research programs. They go on to postdoctoral fellowships, with many now serving as principal investigators in academia and industry. We request 6 T32-funded positions.

Public health relevance
PROJECT NARRATIVE For over three decades the PhD training program in Molecular Pharmacology and Experimental Therapeutics (MPET) in the Mayo Clinic Graduate School of Biomedical Sciences (MCGSBS) has been training outstanding researchers with the interdisciplinary background and skills to make exciting basic research discoveries and then propel these discoveries toward novel therapies for human diseases. We are requesting funding to support a program with a track record of producing outstanding scientists.